Family Matters: Optimizing Family-Based Interventions for Adolescents with Type 1 Diabetes

Project Summary/Abstract
Adolescents with type 1 diabetes (T1D) often experience deteriorations in glycemic control that can persist into
adulthood. Although family-based interventions are empirically supported to offset this adolescent risk, such
behavioral health services are rarely included in diabetes care. This K23 proposal seeks to bridge this gap
between research and practice by optimizing family-based programs to provide the most efficacious, judicious,
and streamlined intervention possible to adolescents with T1D. The proposed study aims to 1) pilot and
evaluate specific family-based intervention components, and 2) identify the factors that explain and influence
intervention effects. First, the candidate will use qualitative methods to pilot 3 intervention modules to assess
feasibility and acceptability. Each module corresponds to one of 3 critical family processes: parental
monitoring, parental involvement, and parent-adolescent conflict, each of which are empirically linked to
adolescent diabetes management and glycemic control and are common family-based intervention targets.
Next, the candidate will conduct an experimental trial of the intervention modules to evaluate their relative
efficacy as well as combined impact on adolescent outcomes. Finally, the candidate will conduct advanced
statistical analyses to verify the specific family processes (including both general and diabetes-specific) that
explain (mediate) program effects as well as the contextual factors that influence (moderate) intervention
effects. This proposal will yield an optimized family-based intervention as well as provide critical empirical
information about the causal pathways between family functioning, mental health, and glycemic control among
adolescents with T1D. The K23 award offers the training, mentorship, protected time, and resources necessary
to complete the proposed study and support Dr. Wong’s progress toward becoming an independent research
scientist in pediatric diabetes.

Public health relevance
Project Narrative Deteriorations in glycemic control are common among adolescents with type 1 diabetes (T1D). Although family-based interventions are empirically supported to bolster disease management during this period, they are not widely implemented. The current study seeks to optimize family-based interventions for adolescents with T1D to provide a judicious, streamlined, and robust program to be implemented within diabetes care.